Auditory–motor interactions in neural processing and the frequency-following response

ECR R21 – Project Summary
The central auditory system modulates its responses to self-generated sounds that result from an
individual’s movements. However, how the human auditory system balances two competing
functions—coarse attenuation of self-generated sounds allowing us to remain vigilant to the
external environment, and fine-grained accentuation of unexpected sounds to monitor for
prediction errors—is not well-understood. We will use the frequency-following response (FFR)—
which measures the fidelity of a sounds’ representation in the early auditory system—to assess
the timing and location of auditory–motor interactions in the auditory system, whether subcortical
or in primary auditory cortex. We will then uncover how early auditory processing of self-generated
sounds is modulated when the auditory stimulus is unexpected and therefore does not align with
sensory predictions. Separately, but in the same participants, we will use functional magnetic
resonance imaging (fMRI) to identify cortical neural processing of auditory–motor interactions
when hearing both expected and unexpected stimuli during active and passive sound
presentation. Finally, we will directly compare early auditory FFR representations and later
auditory cortical fMRI representations to map the neural processing of self-generated and
expected sounds. By assaying auditory perception across self- vs. passive generation and
expected vs. unexpected contexts, as well as by synthesizing non-invasive methods for imaging
early and later auditory processing, this project will uncover fundamental information about how
the human brain processes self-generated and passively perceived sounds, and how that
processing changes when the sounds are unexpected vs. expected.

Public health relevance
ECR R21 – Project narrative Interacting with the external world through motor action has sensory consequences that our brains often want to ignore but sometimes want to highlight—but how the human auditory system performs these two functions is not well-understood. We are using two complementary non- invasive methods to discover how the subcortical and cortical auditory systems process self- generated sounds that are expected and unexpected. Our project will advance our understanding of neural processes that are dysfunctional in communication disorders such as persistent developmental stuttering, with significant potential to aid in diagnosis and the measurement of therapeutic treatments.